SAFETY AND BIOLOGIC ACTIVITY OF RHU GM-CSF AND RHU IL4 TO TREAT CANCER

The human immune system, when appropriately stimulated, has the capacity to recognize and destroy cancer cells. While many pathways of tumor killing have been identified, the most potent is that mediated by tumor- specific cytotoxic T-lymphocytes (CTL,1). The generation of these CTL requires a number of essential components including the presence of tumor antigens, specialized antigen present in cells (APC) and tumor- reactive T cells (2).